Administration and statistical/bioinformatics core

PROJECT SUMMARY
This program project grant (PPG) proposes to explore important, fundamental aspects of aging that can
result in the loss of brain function that occurs during aging. This loss of brain function, often termed
Alzheimer's disease (AD) and related dementias (ADRD), imposes enormous emotional and financial burdens
on citizens of the United States, and worldwide. Core A will organize and coordinate the entire PPG, and will
be crucial for the success of its scientific goals. The Core will be led by the PPG Principal Investigators Judith
Campisi and Lisa Ellerby. It will provide essential functions to the PPG, which will be implemented through
seven interlinked specific aims. These aims include facilitating communication and collaboration among the
Projects (Projects 1-3) and other Cores (Cores B-D), organizing regular meetings among the Project and Core
personnel and members of the Scientific Advisory Board (SAB), which will provide critical assessments of the
scientific and administrative progress of the PPG. Core A will also provide budgetary and administrative
support and oversight, be responsible for communicating with the National Institute on Aging (NIA), including
submission of progress reports and discussions of any new or altered scientific directions. In addition, Core A
will facilitate and organize training and travel for SAB members and, importantly, for junior participants in the
PPG (students, postdoctoral fellows, critical support personnel). Finally, Core A will provide unified high-level
statistical and bioinformatic support to the entire PPG through dedicated hardware, software and personnel
overseen by Buck faculty member David Furman. Through these aims and services, Core A will provide
critical central administrative and scientific support to the PPG, which will optimize the success of its scientific
aims.